Development of a Neutrophil Degranulation Inhibitor to Treat ARDS

Project Summary
Acute respiratory distress syndrome (ARDS) is a critical problem in pulmonary medicine, accounting for
10% of intensive care unit (ICU) admissions and totaling over 200,000 patients/year in the U.S. Current
treatment cost typically exceeds $70,000 per patient. Decades of clinical trials failed to identify effective
pharmacologic therapy for ARDS, while mortality remains above 30%. Thus, there is a critical, unmet clinical
need for successful pharmacologic strategies to treat ARDS. Neutrophils play an essential role in the lung
injury leading to ARDS, including that due to COVID-19, through extracellular release of reactive oxygen
species (ROS), granule constituents, and neutrophil extracellular traps (NETs). The scientific foundation
underlying our innovative therapy is that inhibition of neutrophil degranulation also prevents release of ROS
and NETs, making degranulation a therapeutic target. We generated a recombinant protein, degranin-23
(degranulation inhibitor of SNAP-23, DGN-23) containing a SNARE motif from SNAP-23 and a cell
permeability peptide. DGN-23 rapidly enters human neutrophils in vitro and in vivo, inhibits degranulation by
50% to 80%, prevents priming of ROS release, and reduces NET formation. Importantly, in vitro studies show
DGN-23 does not impair neutrophil phagocytosis, granule fusion with phagosomes, or bacterial killing within
phagosomes, and in vivo studies show that DGN-23 administration at the initiation of lung injury inhibits acute
lung injury in 3 rodent models, without obvious toxicity. Thus, in vitro and in vivo data provide strong support for
our novel therapeutic strategy that inhibition of neutrophil exocytosis attenuates lung injury leading to ARDS.
The next steps are development of manufacturing capability and quality control to move from a laboratory
grade recombinant protein to a pharmaceutical grade drug and validation of therapeutic effect without toxicity
under clinically relevant conditions. This transition will be accomplished by two Aims. Aim 1: Characterize
production characteristics and off-target/side effects of DGN-23. This aim will determine purity, presence
of bacterial contaminants, yield, reproducibility of potency, and stability in multiple production runs of DGN-23.
Cell toxicity and off target effects on circulating immune cells will be determined. Organ and cell localization of
DGN-23 will be determined in all major organs from animals undergoing experiments described in Aim 2. Aim
2: Determine therapeutic efficacy of DGN-23 under clinically relevant conditions. The ability of DGN-23
to prevent acute lung injury and improve mortality when administered at various times after the initiating injury
will be determined in a mouse model of H1N1 influenza virus-induced acute lung injury. Improved survival and
improved blood oxygenation will serve as outcomes to proceed with development. At the conclusion of this
work, this Phase 1 project will have identified a drug candidate with an optimal combination of efficacy, yield,
stability, and potency to advance to advanced pre-clinical studies in a Phase 2 project.

Public health relevance
Narrative Acute respiratory distress syndrome (ARDS) is a common, life-threatening complication in ICU patients with no effective drug therapy. Successful completion of the proposed pre-clinical studies will lead to development of an effective non-viral biologic that treats the acute lung injury responsible for ARDS.